Research Supplements to Promote Diversity in Health-Related Research

Candidate’s Project Abstract:
Biological phase separation phenomena contribute to many fundamental cellular organization and regulatory
processes, from transcription to post-transcriptional gene regulation, and have recently been identified as a
pathophysiological hallmark of two prominent neurodegenerative diseases, amyotrophic lateral sclerosis (ALS)
and frontotemporal dementia (FTD). Stress granules (SGs), macromolecular complexes of RNAs and RNA
binding proteins (RBPs) that assemble in response to stress-elicited inactivation of translation initiation, are an
actively studied example of a regulatory biological phase separation process and a prominent experimental
model in the field. Despite the well-established finding that SG biogenesis is a ubiquitous cellular response to
stress-induced translational suppression, there remain substantial gaps in our understanding of SG biogenesis.
Among the most significant gaps is an understanding of the biological criteria for mRNA recruitment into SGs.
Transcriptome analyses of isolated SGs have provided limited insights into SG recruitment criteria, revealing a
positive correlation with CDS and UTR length and a negative correlation with translational efficiencies. An
additional and unexpected finding from SG transcriptome analyses was that endoplasmic reticulum (ER)-
targeted mRNAs are substantially under-represented in SG mRNA transcriptomes. This finding is all the more
unexpected in light of recent finding that ER dynamics are functionally coupled to SG biogenesis and regulate
granule biogenesis and fusion. How the ER contributes to SG biogenesis while its associated mRNAs are largely
sequestered from these regulatory organelles is unknown. An additional important and as yet unexplained
observation is that on average, only a small fraction (< 10%) of a given mRNA is recruited into SGs. It is not
currently known if this fraction comprises a random, stochastic sampling of the cellular mRNA population or,
alternatively, a distinguishable cohort of mRNAs. Addressing these gaps in knowledge will be accelerated by
experimental models that enable molecular dissection of these questions. To this end, we recently discovered
that SGs assemble on the ER in response to activation of the unfolded protein response (UPR) and, critically,
that mRNA recruitment into ER-associated SGs is gene-selective. Intriguingly, we also discovered that SG
biogenesis is intimately linked to, and dependent upon, de novo transcription. These findings are significant
because they suggest that SG biogenesis is restricted to newly exported mRNAs, is spatially organized on the
ER membrane, and reveal divergent fates for mature vs. newly exported mRNAs during the cellular response to
stress. By identifying molecular signals for the recruitment of mRNAs into SGs and determining how transcription
and SG biogenesis are coupled, we expect that the candidate’s research will advance understanding of stress
granule biology and its regulatory roles in post-transcriptional gene expression.

Public health relevance
Project Narrative (from parent grant): Mammalian cells use biological zip codes to transport mRNAs, which encode the information for the synthesis of proteins, to specific locations in the cell, so that proteins are made in their appropriate location. This RNA localization process is critical to early development, learning and memory, and at the level of the individual cell, to the secretion of hormones and neurotransmitters as well the cell surface localization of proteins functioning in signaling and cell-cell communication. The findings from this study are expected to reveal new mechanisms of RNA localization and identify conserved pathways that may be dysregulated in diseases of development, metabolism, and ageing.